Administrative Core

An efficient administrative structure is essential to the design and implementation of this U19 Program. The Administrative Core is designed to facilitate communication, planning, data sharing, and scientific and fiscal oversight of the component research projects of the Program. Through Core A, the Core Director will oversee all the goals of this research Program. The Core Director will serve as the primary contact between project investigators, and will serve as the liaison between this research group and the NIH program staff. The Core will fund the shipping of reagents and materials between research sites, and will fund the annual travel of the External Advisory Board to the Program site of review. The Core Administrative Assistant will coordinate, schedule, and implement minimum monthly internal meetings and teleconferencing among the Program sites, and will prepare progress reports, internal compliance filings and edit manuscripts to support the Program. The Core will oversee data sharing, data archiving, and overall record keeping of the Program.

Public health relevance
The Administrative Core is essential to facilitate our program of study aimed at defining the mechanisms of immune control of flavivirus infection.